Developmental Funds

Developmental Funds: Summary/Abstract
The strategic goal behind deployment of developmental funds is to catalyze collaborative research in the
three Center-wide themes of Impactful Discovery (Theme 1), Effective Translation (Theme 2), and
Implementation and Dissemination (Theme 3). Allocation of these funds is tightly linked to the formal planning
and evaluation activities of the HDFCCC, to ensure that deployment of funds aligns with HDFCCC-wide
strategic plans and leadership priorities. This is done through funding in two key areas: pilot projects and
salary support for early-career clinical faculty. For pilot projects, from all sources since 2018, the HDFCCC
has awarded $11.2M across more than 140 awards, resulting in over $59M in subsequent funding and 52
publications to-date. For early-career faculty support, since 2018, $181,500 has been given to eleven
investigators, resulting in $1,382,144 in subsequent funding and eight publications.